Pancreatitis-induced initiation of early onset pancreatic cancer

Abstract
Early onset pancreatic cancer (EOPC, <50 years of age), though historically uncommon, is rising in
prevalence and frequently presents at advanced stages, underscoring an urgent need for improved early
detection strategies and insights into the underlying mechanisms of pancreatic oncogenesis. Chronic pancreatitis
(CP), a significant risk factor for pancreatic ductal adenocarcinoma (PDA) and specifically correlated with EOPC,
is characterized by profound fibroinflammatory and epigenetic alterations, potentially facilitating KRAS-driven
tumor initiation. However, exploration of this process has been constrained by the scarcity of robust human
disease models. To address these challenges, we have pioneered the development of patient-derived organoid
(PDO) biobanks for normal pancreas (NP), CP, and PDA tissues. Our preliminary studies demonstrate that CP
PDOs retain the genetic, transcriptomic, and functional attributes of primary patient tissues, including enhanced
fibroinflammatory signaling and ductal dysfunction. In this proposal, we leverage these PDO models to elucidate
the mechanistic role of CP in potentiating EOPC initiation. Using immortalized PDOs, we will introduce KRAS
mutations to define differential proliferative and oncogenic signaling dynamics between NP and CP backgrounds,
complemented by orthotopic transplantation to assess tumorigenic potential in vivo. Furthermore, our
comprehensive PDO platform facilitates the identification and validation of novel biomarkers capable of
distinguishing EOPC from benign pancreatic conditions like CP. By integrating transcriptomic and proteomic
approaches, we prioritize biomarkers with reciprocal expression patterns between PDA and CP. Validated
candidates will undergo rigorous evaluation in patient sera, leveraging logistic regression modeling to refine
diagnostic accuracy. This integrative approach promises transformative insights into early pancreatic
oncogenesis, identifies mechanisms underpinning CP-driven cancer initiation, and accelerates the development
of clinically relevant biomarkers for early EOPC detection, thereby enhancing patient prognoses.

Public health relevance
Project Narrative Early onset pancreatic cancer (EOPC) is rising in prevalence, frequently diagnosed at advanced stages, and strongly associated with chronic pancreatitis (CP), necessitating improved models and biomarkers for early detection. We developed robust patient-derived organoid (PDO) models of CP and normal pancreas tissues to investigate the mechanisms by which CP drives EOPC initiation. Using integrated transcriptomic and proteomic analyses, we will identify biomarkers that effectively distinguish EOPC from benign inflammatory conditions, enhancing early diagnosis and clinical outcomes.